COLORADO ADOLESCENT MATERNITY PROGRAM

This is a prospective, randomized, controlled trial of the efficacy of a multi-disciplinary, adolescent-oriented maternity program at preventing one of the most serious neonatal complications associated with adolescent pregnancy - preterm delivery.